Smart Cavity Creator Drill for Lumbar Interbody Fusion: Direct to Phase II

Project Summary
More than 500,000 lumbar fusion surgeries are performed each year in the United States, but new leg pain from
iatrogenic nerve root injury remains a complication in 5% to 16% of patients. The interbody fusion portion of the
surgery involves time-consuming and technically challenging steps of nerve root exposure and retraction, cau-
terization of bleeding around the nerve root, dorsal root ganglion and epidural space, removal of disc material
from vertebral end plates using manual knives, rongeurs, curettes and rasps, and then insertion of an interbody
cage implant containing bone graft. Surgical dissection must be as large as the cage, which is usually 7 mm to
18 mm tall and twice as wide, and hence, longer operative time, more blood loss, and more frequent nerve root
injury and dural tear are reported with interbody fusion even for current minimally invasive methods. A safer
technique is needed. In this Direct to Phase II SBIR application, we propose to commercialize a novel lumbar
interbody fusion technology that uses a very small approach channel to create a large cavity in the center of the
disc space to allow bone growth and thus avoid risks associated with complex surgical dissection. This technique
(“Smart Cavity Interbody Fusion” or “SCIF”) is based on strong proof-of-concept demonstrations of successfully
integrating a cavity-creating drill with smart sensors to substitute for manual instruments and direct visualization.
We have shown that this sensor-enabled, articulated drill bit (“Smart Cavity Creator” or “SCC”) can reproducibly
create precise cylindrical cavities ranging from 4 mm to 16 mm in diameter within the disc space through a small
access shaft of only 3.2 mm diameter. Further, that a drill guide can be locked rigidly to lumbar spine pedicle
screws to define pre-specified drill trajectory and cylindrical cavity dimensions, and that sensors integrated into
the drill bit can trigger automatic shut-off when changes are detected during transitions, for example, from disc
material to vertebral body cortical end plate bone and then vertebral body cancellous bone. Sensors enhance
procedural safety and speed compared to current manual methods. Our aims are (1) to simplify the drill guide,
(2) to conduct in vitro validation of SCIF to the currently most common interbody fusion technique as the gold
standard: Transforaminal Lumbar Interbody Fusion (TLIF), and (3) to conduct in vivo validation of SCIF vs. TLIF
for fusion success, safety outcomes, efficiency, and usability in 20 live pig experiments with survival to 3-months.
Validation will achieve “Design Freeze” of the technology. We have requested a pre-submission meeting with
the FDA and will prepare Quality Management System (QMS) for regulatory submission. A major medical tech-
nology company, Globus Medical, is interested in acquiring the technology if the proposed validation studies are
successful.

Public health relevance
Project Narrative Our goal is to commercialize a novel lumbar interbody fusion technology that reduces risk of nerve root and blood vessel injury associated with surgical dissection: The Smart Cavity Creator (SCC) that uses an articulated drill bit to create cavities in the intervertebral disc large enough to allow new bone growth (interbody fusion). Electrical impedance and torque sensors in the SCC detect transitions in drilled tissue transitions to enhance safety. We now propose to simplify the SCC drill guide to improve handling, and then to compare success, safety, efficiency, and usability of this new surgical technique (“Smart Cavity Interbody Fusion” or “SCIF”) to the currently most common interbody fusion technique (“Transforaminal Lumbar Interbody Fusion” or “TLIF”), first in pig ca- davers, and then in live pigs.